Molecular lanterns for multiplexed imaging of RNA dynamics

Project Summary
RNAs play pivotal roles in diverse cellular processes ranging from memory formation to immune activity.
Key questions remain, though, regarding the location, degradation, and dynamic interactions of multiple
transcripts. This is due, in part, to a lack of robust methods to track RNAs in real time and in physiological
settings. Conventional approaches rely on RNA tags coupled with fluorescent probes. Many of these tags
are too large to use in conjunction with small RNAs. Additionally, the readouts require excitation light, which
can damage biological samples upon repeated exposure. External light can also induce autofluorescence,
precluding sensitive detection of low abundant targets. Capturing a broader set of RNAs—and the complete
picture of their biological roles—requires new technologies.
Our long-term goal is to develop enabling platforms for visualizing RNAs and their dynamics. The objective
of this proposal is to build one foundational technology featuring ultra-small RNA tags that can assemble
split luciferases. Signal production will only be observed when target transcripts (bearing the small tags) are
present. Guided by strong preliminary data, our work involves (1) generating orthogonal RNA tags and
complementary split luciferase binders, such that multiple transcripts can be visualized at once; (2)
developing a platform for continuous, multiplexed imaging. This aim will make use of bioluminescent
phasor, a method for rapid assignment of overlapping and often complex luciferase emission spectra. The
experiments will establish optimized parameters for deploying combinations of the RNA tools in biologically
relevant systems, and for continuously tracking their abundance and location. A third aim involves
benchmarking the imaging probes and methodology against challenging targets, including endogenous and
low-abundant RNAs, and collections of differentially expressed transcripts. Collectively, our work removes
technical barriers to imaging RNAs and their dynamic functions, marking a significant advance over existing
state-of-the-art approaches.

Public health relevance
Project narrative The proposed research is relevant to public health because the development of novel luminescent imaging tools and methods is expected to facilitate studies of RNA dynamics in live cells, tissues, and organisms. Such tools could guide the development of new classes of therapeutics and diagnostics. Thus, the proposed research is relevant to the NIH’s mission that pertains to gaining fundamental knowledge about the nature of living systems and reducing the burdens of disease.